Administrative Supplement for: Language difference or difficulty learning? Assessing early language skills to identify risk for reading difficulty among young Spanish-English dual language learners

From the parent grant: A major challenge in educational health research is that there are no well-
established approaches for reliably identifying early signs of reading difficulty among dual language learners
(DLLs). Given the value of literacy to individual well-being and the importance of early identification to maximize
educational growth, there is a critical need to optimize assessment to identify Spanish-English DLLs at risk for
reading difficulty early in the elementary years. Consequently, the long-term goal of the proposed research is to
establish practical, reliable methods for early identification of reading disability among DLLs. Representing one
step toward this goal, the overall objective of this project is to identify assessments of kindergarten language and
preliteracy that: (1) reliably predict Spanish-English DLLs’ reading development one year later and (2) are
highly sensitive for identifying DLLs classified as being at risk for reading difficulties in grade 1. We hypothesize
that measures that tap multiple underlying domains of linguistic knowledge will most strongly predict future
reading development, but that the relations between early language and later reading will be inconsistent across
DLLs, depending on dual language exposure, use, and early code-based literacy skills. We further hypothesize
that measures of transferable language skills will provide optimal single-measure discrimination for predicting
reading difficulty in grade 1, but that assessment in both languages will be necessary to achieve good
classification accuracy. To test these hypotheses, two specific aims will be addressed. First, this project will
identify measures of DLLs’ English and Spanish language skills in kindergarten language that reliably predict
reading achievement in grade 1. Second, we will determine the classification function of standardized measures
of dual language abilities for identifying Spanish-English DLLs at risk for reading difficulties in grade 1. To
achieve these aims, children will complete assessments of Spanish and English vocabulary knowledge,
morphosyntax, early code-based literacy skills, narrative macrostructure, and narrative microstructure during
kindergarten. Their parents and teachers will also be asked to describe the children's dual language exposure
and use across the home and school environment. One year later, during grade 1, children will complete
measures of decoding and reading comprehension in English and Spanish. This work is significant because
early, reliable prediction of literacy difficulties is critical to prevent students from falling behind their peers during
the early elementary years. Early identification of DLLs likely to have difficulty learning to read allows educators
to allocate specialized resources and individualized instruction to maximize gains for those students. This work
is innovative because it directly attends to the heterogeneity of the DLL population, examining how dual language
exposure and use may influence language and reading skills across two years of schooling, focusing on the first
years of elementary education. This work aligns with NICHD’s mission to maximize the potential of all children
to live healthy and productive lives.

Public health relevance
Project Narrative “The proposed research is relevant to public health because it will lead to practical methods of identifying risk for reading difficulties among Spanish-English speaking dual language learners early in life, which has implications for preventing reading disability prior to its onset. Therefore, this research project is aligned with the part of NICHD’s mission pertaining to ensuring that all children reach their full potential for healthy and productive lives.”